Mechanisms of Ciliary Signaling Controlling Obesity and Metabolic Disease

This project focuses on understanding a fundamental cellular mechanism underlying a range of important
physiological signaling in humans including the control of feeding and obesity. The mechanism uses an ancient
cellular signaling organelle, the primary cilium, to control responses to satiety signals generated following feeding.
Bardet-Biedl syndrome (BBS) is a rare human syndrome called a ciliopathy because of mutations in genes encoding
components of the primary cilium. Patients with BBS have inherited mutations in genes linked to a complex called
the BBSome, discovered in our laboratory, that fail to present receptors critical to limit feeding after a meal. Our
work has found that cilia also control adipogenesis via the de novo generation of new fat cells and the secretion of
insulin and glucagon in pancreatic islet cells. We have focused on mechanisms of ciliary signaling and trafficking,
enabled by the use of affinity purification/mass spectrometry to identify new components of the ciliary machinery.
These studies have been initiated by using the ciliopathy disease genes as bait proteins to find new components
and cell biological pathways linked to ciliary traffic and signaling. A number of these newly discovered components
are themselves mutated in human pedigrees linked to obesity. In particular, a ciliary structure called the distal
appendage serves as a critical gate for entry of ciliary receptors. We find that mutations in components of the distal
appendage are linked to monogenic obesity syndromes. As monogenic obesity syndromes are rare, the lab has
shifted to systematically surveying public data for over 750,000 patients in Genome Wide Association Studies
(GWAS) for genes found to be altered in patients with high Body Mass Index (BMI) (a key measure of obesity) and
diabetes. We have discovered 100s if not 1000s of candidates for a substantially broader list of candidates for
obesity drivers linked to cilia in nonconsanguineous populations. In Aim 1 of this proposal, we will further explore
the mechanisms by which the distal appendage is assembled and how that organizes trafficking into the cilium. In
Aim 2, we will examine how the distal appendage traffics receptors and generates signals in the cell. In Aim 3, we
will explore a new factor of the distal appendage, called CCDC92, which potentially controls signaling via proteolytic
destruction of ciliary signaling regulators. In each Aim, we will use genetic lesions derived from patients with high
BMI which we find have screened for defects in ciliary trafficking or signaling. Our goals are to continue to explain
obesity lesions to allow accurate assessment of a patient’s genetic obesity drivers, to identify additional druggable
targets for obesity and diabetes therapeutics, and to communicate these findings to the public to help predict dietary
susceptibilities based on molecular genetic profiles. By identifying signaling pathways defective in obesity and
diabetes, we can identify targets to protect or restore these tissues and molecular profiles of patients to facilitate
patient selection for treatments to improve obesity and metabolic disease.

Public health relevance
Project Narrative This project seeks to understand a fundamental mechanism controlling feeding and obesity in humans, which is organized in part by the primary cilium, an ancient signaling organelle in the cell. Using human genetics, proteomics and quantitative cell biology, we have found that genes encoding proteins within the cilium are mutated in rare inherited syndromes, but more recently found 1000s of cilia-linked mutations in humans with obesity or high Body Mass Index (BMI) causing signaling molecular defects, which we will study here. By examining new genes and signaling mechanisms, we endeavor to explain and quantify the effects of cilia-related obesity lesions in patients, to identify new targets for treating obesity and metabolic disease, and to facilitate patient diagnosis and selection for molecularly rationale therapies and precise therapeutic choices.